Development of IMYX-3 for the Treatment of Ulcerative Colitis

Abstract
Ulcerative colitis (UC) is a chronic, idiopathic inflammatory disease that affects the
colon, most commonly afflicting adults aged 30–40 years and resulting in disability. UC is
characterized by relapsing and remitting mucosal inflammation, starting in the rectum and
extending to proximal segments of the colon. Existing biological treatments have proved
effective for some patients, yet up to one third of moderate-severe colitis patients are refractory
to these therapies and may require colectomy. Novel biological targets are needed to modulate
the dysregulation of the intestinal epithelial cells (IECs) as well as the activated intestinal
immune population causing excessive host damage. RAB27A belongs to the RAS superfamily of
monomeric G proteins and has been shown to localize to specific cellular compartments to
regulate membrane trafficking in numerous cell types. Recent reports have shown its
upregulation in UC patient colon samples, both in the intestinal epithelial cells and the
surrounding immune population. In mouse models of UC, knock-down of RAB27A has been
shown to improve the disease phenotype. RAB27A activity has also been shown critical to the
toxic function of certain refractory immune cells including the neutrophil, NK-cells and dendritic
cells
. Notably, studies have suggested a potential role for neutrophil modulation in improving
disease outcome. Both results from UC rodent models and descriptive clinical studies have
shown that activated neutrophil toxicity is present and damaging to the colon, indicating that
lowering its effect could substantially alleviate disease burden particularly in refractory patients.
Nonetheless, currently there are no RAB27A or neutrophil targeting therapeutics in the clinic. To
this end, Immunyx Pharma has developed a soluble small molecule RAB27A inhibitor to block
the deleterious activities of the protein in ulcerative colitis. Our lead compound, IMYX-3 has
already shown efficacy in rodent inflammatory models and has demonstrated positive PK and
toxicity results. In this Phase II application, we will define, optimize and validate a treatment
regimen and dosing for IMYX-3 in advanced models of mouse ulcerative colitis. Based on these
murine validation and dosing studies, we will evaluate specific pharmacokinetic data for the
therapeutic window. Next, we will prepare our drug formulation for GMP manufacturing and use
this validated batch for our GLP toxicity studies in rodents. These key milestones will form the
basis of FDA regulatory filings and prepare IMYX-3 for first in human studies.

Public health relevance
Project Narrative (Public Health Relevance Statement) Ulcerative Colitis (UC) is a chronic inflammatory bowel disease (IBD) affecting almost 1 million Americans, that results in ulceration of the large intestine (colon and rectum) leading to debilitating and even life-threatening complications including increased incidence of colorectal cancer (CRC). While the etiology of UC is unknown it appears to involve a dysregulated immune system and current therapies primarily comprise immune modulators. This proposal seeks to advance development of a novel therapeutic for improving patient response by modulating the protein RAB27A, a target shown to underly toxic immune response in the colon and damage to the intestinal epithelial cells.